Program to Increase Diversity in Cardiovascular Health-Related Research (PRIDE-CVD)

This proposal aims to continue support for the Program to Increase Diversity in Cardiovascular Health-Related
Research (PRIDE-CVD) at the State University of New York (SUNY) Downstate Medical Center in Brooklyn,
New York. The goal of the PRIDE-CVD is to instruct scientists/clinicians in multidisciplinary approaches to
research in cardiovascular health disparities using Brooklyn as a living laboratory. The PRIDE-CVD and before
it, SIPID-CVD (Summer Institute Program to Increase Diversity) have been in existence for 12 years and have
trained 89 mentees from 78 Universities nationwide. As a result of this training, 55% of SIPID/PRIDE-CVD
mentees successfully secured peer reviewed funding from NIH and non-NIH institutions; 36% were promoted
from Assistant Professor to Associate Professor and their publications increased by 5-folds. In addition, 58% of
SIPID/PRIDE-CVD mentees submitted grant proposals currently under review. To continue to build on this
success and years of experience, the renewal Program has the following Specific Aims:
1: To select and train qualified underrepresented scientists/clinicians who have potential to contribute
to the knowledge in cardiovascular health disparities research;
2: To provide long-term tailored one to one and peer mentoring with the goal to submit a research grant
application;
3: To provide intensive individualized training and guidance in grant writing and peer review in order to
enhance the capacity for success in research careers;
4: To provide financial support for small research projects to facilitate transition to independence;
5: To evaluate long-term effectiveness of PRIDE-CVD.
The PRIDE-CVD at SUNY Downstate is characterized by: 1) its partnership with minority-led community-based
organizations with expertise on health disparities; 2) the living laboratory of Brooklyn, New York, an urban setting
in which to conduct health disparities and CVD research; 3) a well renown faculty roster with a high number of
minority members; 4) a historical context providing 12 years of experience in training and supporting
underrepresented junior faculty. It is expected that the PRIDE-CVD will continue to contribute significantly to
improving the pool of highly-capable minority professionals in cardiovascular health research. The ultimate goal
in increasing diversity among the ranks of underrepresented scientists/clinicians, is an important step towards
alleviating health disparities in cardiovascular diseases.

Public health relevance
This proposal aims to continue training and mentoring underrepresented junior scientists and those with disabilities by enhancing their research skills in cardiovascular health disparities. The ultimate goal in increasing diversity among the ranks of underrepresented scientists, is an important step towards alleviating heart disease related health disparities. In the 12 years since its inception at Brooklyn SUNY Downstate Medical Center, the program has trained 89 underrepresented scientists, the majority of them are now funded or on their way to obtaining research funding and pursuing independent academic careers.